ORBITAL RADIOTHERAPY FOR GRAVES'OPHTHALMOPATHY

The aim is to define the role and efficacy of radiotherapy in the treatment of Graves' eye disease. Patients will be treated in one orbit and again at 6 months in the other orbit, and measurements made over a three year period to evaluate effects.